Expanded Program in Occupational Injury and Illness Surveillance

Project Summary/Abstract
Michigan State University in conjunction with the Michigan Occupational Safety and Health Administration
(MIOSHA) and the Michigan Department of Health and Human Services has been conducting state-based
occupational injury and illness surveillance since 1988. This proposal will continue and expand this activity.
This proposal will fund activity to generate the occupational indicators, data on elevated blood leads, and
specific non-fatal injuries (e.g. burns), ten special projects and expanded surveillance programs for: (1)
occupational lung disease; (2) acute work-related pesticide injuries and illness; (3) acute work-related acute
traumatic fatalities. Since initiation of multi-source surveillance, cases of work-related asthma, cases of acute
pesticide poisoning, cases of silicosis and other lung diseases, elevated blood lead levels, and both acute
fatal and non-fatal traumatic injuries have been confirmed. This case-based surveillance has initiated follow-
back enforcement MIOSHA inspections in the worksites. These inspections have included interviews of
fellow workers. The confirmation process, workplace inspections and fellow worker interviews will be
continued. There has been 100% reporting from the 134 acute care hospitals in the state. A quarterly
newsletter (four/year for 31 years) has been written and mailed out to approximately 3,300-targeted
physicians and health care professionals. Two hundred and three annual reports and 51 hazard alerts have
been disseminated. The above active outreach to encourage reporting and educate employers and
employees about hazards will be continued as will presentations and display booths at medical meetings,
publishing papers in the medical literature, postings on our website (oem.msu.edu), Twitter, and Facebook,
the NIOSH Science Blog and through the medical licensing board. We will continue to work with NIOSH,
CSTE, other states, trade organizations and unions. Evaluation of the effectiveness of our effort to improve
working conditions will also continue. Innovations in this application including expanding our educational
outreach, and ensuring that we address the hazards of vulnerable populations and minorities, as well as
temporary workers and youth follow back. New activity planned includes expanding surveillance to include
exposure surveillance, additional nonfatal traumatic injuries, projects on under-reporting, evaluation of
MIOSHA inspections for following up reported cases and projects on special populations and industrial
sectors.

Public health relevance
Project Narrative This project is relevant to public health, and specifically occupational health and safety, because it addresses all three core functions in public health: collection and analysis of data, building partnerships to promote the goal of tracking and using the data to prevent occupational injuries and illnesses. A variety of strategies will be used to ensure that surveillance data are of high quality, that stakeholders and the public are aware and have access to the data, and that the data drive prevention activities.